Biomarkers of Mild and Moderate Traumatic Brain Injury

DESCRIPTION (provided by applicant): Research in the field of truamatic brain injury (TBI) has long been dominated by research on severe brain injury, yet mild and moderate TBI (MMTBI) comprise over 90% of all cases. The pathophysiology and severity of MMTBI are difficult to determine from clinical and radiological measures acutely. Physicians and researchers are limited by the lack of clinical tools for risk stratification of these patients soon after their injury. Many investigators have suggested that the lack of biomarkers of injury has contributed to the gap in knowledge of TBI pathophysiology and the failure of clinical trials. Biochemical markers of injury would serve to improve clinical care of these patients in many ways, such as: 1) assessing risk for intracranial bleeding;2) determining need for diagnostic imaging;3) determining need for neurosurgical intervention;4) assessing need for admission;5) helping with return to play/work/duty decisions;6) determining risk for long-term impairment;and 7) helping to reduce exposure to ionizing radiation. Moreover, from a research perspective, biomarkers could provide clinical trial outcome measures that are quick and cost-effective and help to identify long awaited drug therapies. Unique to this proposal is the assessment of biokinetic properties of the individual biomarkers that will provide insight into their temporal profiles and half-lives. Three novel serum-based assays will be assessed in this protocol as will two already commercially available assays. Specific Aim 1 will assess the diagnostic utility of these five candidate biomarkers in MMTBI patients by examining relationships between levels of specific biomarkers in blood and injury severity, intracranial abnormalities on CT scan, and need for neurosurgical intervention. Specific Aim 2 will assess the prognostic utility of candidate biomarkers by examining the relationship between levels of specific biomarkers, their biokinetic parameters, complications and long-term neuropsychosocial outcome. Specific Aim 3 will prospectively validate in a separate group of patients a diagnostic/prognostic panel of biomarkers measured in blood selected on the basis of data from Specific Aim 1 and 2. The results of this study could provide a blood test that could be used immediately after injury to diagnose and treat patients with TBI. Ultimately, we hope this proposal will provide physicians and researchers the tools they need to improve patient care and long-term outcome in patients with TBI. PUBLIC HEALTH RELEVANCE: Despite many years of research, there are no blood tests commercially available to diagnose a brain injury. The proposed study will work to develop a blood test (biomarkers, or substances that are not normally present in our blood but are released from the brain after it has been damaged) that doctors could use to diagnose and treat patients after they have suffered a brain injury. These biomarkers could tell us how serious a head injury is through taking a simple blood test, and thus, would revolutionize and improve the care of patients with brain trauma by helping doctors identify injuries earlier, determine if patients need a CT Scan of the head, determine if patients need brain surgery, determine if patients can return safely home or to work or to playing sports, and if patients will have complications from their injury. It would also help researchers to test new treatments for brain injury that could help patients recover and have a better quality of life.